DP21-001 Rhode Island Pregnancy Risk Assessment Monitoring System (PRAMS)

Rhode Island Pregnancy Risk Assessment Monitoring System (PRAMS)
RFA-DP-21-001
Component A – Core Surveillance
RESEARCH & RELATED Other Project Information
Project Summary/Abstract
The Rhode Island Pregnancy Risk Assessment Monitoring System (PRAMS) is part of
the Center for Disease Control and Prevention’s (CDC) initiative to reduce infant
mortality and low birthweight. Based at the Rhode Island Department of Health
(RIDOH), Rhode Island PRAMS (RI PRAMS) is an ongoing statewide population-based
surveillance system designed to collect self-reported information on maternal behaviors
and experiences that occur before, during and shortly after pregnancy among women
delivering live infants in Rhode Island. Response rates are critical to the quality of a
surveillance system such as PRAMS. RI PRAMS has steadily achieved or surpassed
the CDC PRAMS response rate threshold since the inception of the program in RI in
2002.
RI PRAMS randomly selects approximately 170 women from the Rhode Island vital
records birth file each month. Sampled women receive a questionnaire by mail and non-
respondents receive follow-up mailings. Additional attempts to contact non-respondents
are conducted via telephone and in-person at Women, Infant and Children (WIC) sites
which was approved by CDC and implement in RI as an alternative method of data
collection. Data is stratified by low birthweight and normal birthweight. RI PRAMS
materials, including surveys, are available in English and Spanish.
RI PRAMS works in partnership with its Steering Committee, RIDOH programs, other
state agencies and community-based organizations on survey development, data
analysis and dissemination, and policy development to assure PRAMS data are used to
guide decision-making. Key objectives for this project include: maintaining monthly
operations, working with the CDC on survey revisions and system changes, work to
increase response rates among subpopulations, convene PRAMS Steering Committee,
educate healthcare providers and the public, analyze and disseminate data, utilize data
for policy development and program enhancements and protect human subjects.

Public health relevance
Rhode Island Pregnancy Risk Assessment Monitoring System (PRAMS) RFA-DP-21-001 Component A – Core Surveillance RESEARCH & RELATED Other Project Information 8. Project Narrative Rhode Island (RI) PRAMS will promote data sharing and partner engagement at the statewide level by analyzing and disseminating surveillance findings to key stakeholders to facilitate public health decision making. RI PRAMS is not a research training program.